PHASE I DOUBLE BLIND STUDY OF NERVE GROWTH FACTOR IN HEALTHY VOLUNTEERS

This study was designed to assess the safety, tolerance, and possibly the pharmacokinetics of single intravenous or subcutaneous doses of recombinant human nerve growth factor in healthy subjects.